Defining the mechanisms of MSC extracellular vesicle modulation of microglia metabolism and bioenergetics in traumatic brain injury recovery

PROJECT SUMMARY
Neuroinflammation plays a critical role in both the onset and progression of traumatic brain injury (TBI);
however, most therapies are unable to address the multifaceted aspects. Following TBI, microglia
become activated and produce inflammatory cytokines (including TNF-α and IL-6) that damage blood
brain barrier (BBB), tight junctions, and lead to infiltration of peripheral immune cells such as
neutrophils, monocytes, and T cells. Identification of new immunomodulatory strategies that target
microglia and promote a neuroprotective environment is critical for treating this devastating disease.
Mesenchymal stromal cells (MSCs) are a promising therapy for regenerative medicine applications due
to their immunomodulatory function, which is mediated by secreted extracellular vesicles (MSC-EVs)
that possess distinct surface composition and intravesicular cargo. Our group has demonstrated the
ability of MSC-EVs to modulate cell-types involved in neuroinflammation such as microglia, T cells and
pericytes. MSC-EVs are a promising therapeutic for TBI because they can i) have comparable
immunomodulatory function to parent MSCs, ii) cross the BBB, and iii) address safety concerns
associated with MSC delivery (i.e. tumorigenesis and thrombosis). Further, the targeting capabilities
(mediated by surface signals) and MSC-EV cargo can be engineered through priming (preconditioning)
of MSCs with different microenvironmental cues such as cytokines Interferon-gamma and Tumor
necrosis factor alpha. However, there is a gap in knowledge over the role and mechanisms of MSC-EV
modulation of microglia in the context of TBI and whether this effect can be enhanced through priming.
The proposed work seeks to elucidate the mechanisms by which MSC-EVs modulate microglia with a
specific focus on MSC-EV mitochondrial transfer. Our central hypothesis is that MSC-EVs produced
from cytokine-primed MSCs will have greater functionality through modulation of microglia towards a
more neuroprotective phenotype (e.g. reduced production of inflammatory cytokines and reactive
oxygen species) and that this effect is mediated by MSC-EV derived mitochondrial transfer in vitro and
in vivo. We will test this hypothesis in the following aims: 1) Define the mechanisms of mitochondrial
transfer from MSC-EV on microglia metabolism, and 2) Assess MSC-EV therapeutic efficacy in a
porcine TBI model. Successful completion of the proposed work will create a novel, tunable approach
for targeting the brain’s immune system and treating TBI through a better understanding of MSC-EV
mechanisms of action.

Public health relevance
PROJECT NARRATIVE In Traumatic Brain Injury, microglia become activated and produce inflammatory cytokines leading to breakdown of the blood brain barrier, infiltration of immune cells, and further propagation of the neuroinflammatory brain environment. Mesenchymal stromal cells (MSCs) have demonstrated preliminary evidence of modulating microglia; however, the mechanisms of action are unknown. In this project, we aim to explore the ability of MSC extracellular vesicles (MSC-EVs) to target microglia and modulate their inflammatory phenotype through MSC-EV derived mitochondrial transfer and to demonstrate for the first time MSC-EV efficacy in a porcine TBI model.